Transcriptional Determinants of L-Asparaginase Response in Leukemia

Project Summary/Abstract
L-asparaginase is a bacterial enzyme that depletes serum asparagine to inhibit leukemic cell growth in acute
lymphoblastic leukemia. Some patients do not respond to L-asparaginase and the cellular mechanisms
underlying non-response remain poorly understood. Under asparagine deprivation, cells activate a
transcriptional program known as the amino acid deprivation response that is mediated by activating
transcription factor 4 (ATF4). This program culminates in the expression of asparagine synthetase (ASNS), the
enzyme responsible for the synthesis of asparagine. Other than ATF4, the transcriptional regulators involved in
this response are poorly defined.
To identify transcriptional genes involved in the response to L-asparaginase, I developed a CRISPR-Cas9
genetic screening approach to individually knock out each transcription-related gene in the genome. This
approach allowed determination of genes that were required for the resistance of an ALL cell line to L-
asparaginase. The top-scoring gene in my preliminary genetic screen was a poorly described transcription
factor, ZBTB1. Knockout of ZBTB1 sensitized this ALL cell line to treatment with L-asparaginase. Preliminary
work suggested that ZBTB1 enriches in the promoter of ASNS to promote transcription. I hypothesize that
ZBTB1 and the regulation of ASNS expression may be a suitable drug target in asparaginase resistant
leukemia. A lack of insight into the mechanistic role of ZBTB1 in mediating transcription, however, precludes
investigation of this hypothesis.
In this proposal, building on my preliminary work, I will test the hypothesis that ZBTB1 positively regulates the
transcription of ASNS and may be a therapeutic target for L-asparaginase resistant ALLs. In Aim 1, I will
investigate the mechanism by which ZBTB1 regulates the expression of ASNS. In Aim 2, I will determine
whether ZBTB1 knockout sensitizes human ALL cell lines and primary human ALLs to treatment with L-
asparaginase in vivo. I anticipate that these studies will determine: 1) the mechanistic role of ZBTB1 in the
response to L-asparaginase in leukemic cells and 2) the potential of ZBTB1 as a therapeutic target in L-
asparaginase resistant ALL. This work will be completed in the laboratory of Dr. Kivanc Birsoy with the co-
advisement of Dr. Robert Roeder at the Rockefeller University. The training plan outlined in this proposal is
designed to best prepare me for a career as an independent physician-scientist following residency and
fellowship training in hematology and oncology.

Public health relevance
Project Narrative The transcriptional mechanisms underlying the cellular response to L-asparaginase in acute lymphoblastic leukemia remain poorly defined. This proposal seeks to (1) gain mechanistic insight into the role of ZBTB1 in the response to L-asparaginase and (2) evaluate ZBTB1 as a therapeutic target for asparaginase-resistant leukemia. Completion of this work will provide insight into the transcriptional mechanisms by which ALLs develop resistance to L-asparaginase.